UW Comprehensive Cancer Center Support

PROJECT SUMMARY/ABSTRACT
The University of Wisconsin Carbone Cancer Center (UWCCC) seeks continued funding for years 49-53 to
further accelerate its mission to dramatically reduce the burden of cancer within and beyond its catchment – the
State of Wisconsin. The UWCCC, which is a matrix center within the University of Wisconsin School of Medicine
and Public Health (SMPH), is composed of 218 faculty members from 38 departments and 9 schools of the
University of Wisconsin-Madison (UW). Our members pursue cancer care, research, and education through 6
scientific programs (Human Cancer Virology, Cancer Genetic and Epigenetic Mechanisms, Tumor
Microenvironment, Imaging and Radiation Sciences, Developmental Therapeutics, and Cancer Prevention and
Control) supported by 12 Shared Resources. During the current grant period (2017-2021), leadership has
successfully recruited >40 new and more diverse members and strengthened existing or new infrastructure
facilitating our membership publishing 3,351 cancer-relevant manuscripts (31% inter- or intra-programmatic,
53% inter-institutional) with a significant increased proportion in high (≥10) impact factor journals (prior grant,
11% compared to current 23%), increasing our NCI research (Direct 2017 $18.6M, 2021 $24.9M) and total
research funding (Direct 2017 $70.4M, 2021 $76.3M), obtaining more multi-project awards (P, U), supporting
more trainees and supporting communities throughout our expanded catchment.
The UWCCC will accomplish this mission through nurturing a diverse and supportive cancer community, reliable
infrastructure, and efficient resources. The UWCCC worked to decrease the burden of cancer in our catchment
and beyond through prioritized research areas (e.g., innovative therapies and biomarkers, cancer imaging, and
expanded population-based cancer research), enhanced research platforms (e.g., improved clinical research
infrastructure and shared resources), increased efforts to build mission-related philanthropy, and expanded local-
to-global partnerships.

Public health relevance
PROJECT NARRATIVE The University of Wisconsin Carbone Cancer Center (UWCCC), which is a matrix center within the University of Wisconsin School of Medicine and Public Health (SMPH), seeks to dramatically reduce the burden of cancer within and beyond our catchment. Specifically, the UWCCC will do this by decreasing cancer incidence and mortality among populations within our catchment area and beyond, including our minority and underserved populations. We will facilitate pursuit of this goal through partnerships with other health delivery systems and state and community agencies for dissemination of evidence-based findings. The UWCCC will accomplish our goals through nurturing a diverse and supportive cancer community, reliable infrastructure, and efficient resources. During the current funding period, UWCCC continued to decrease the burden of cancer in our catchment and beyond through prioritized research areas (e.g., innovative therapies and biomarkers, cancer imaging and expanded population-based cancer research), enhanced research platforms (e.g., improved clinical research infrastructure and shared resources), increased efforts to build mission-related philanthropy, and expanded local-to-global partnerships.